Regulation of cell proliferation by CRL ubiquitin ligases

PROJECT ABSTRACT / SUMMARY
Over four decades have elapsed since the discovery of the ubiquitin-proteasome system, yet our
comprehension of its regulatory intricacies remains incomplete. This knowledge gap persists largely due to the
limited characterization of the multitude of ubiquitin ligase enzymes, numbering approximately 600 in
mammals. Within our laboratory, our primary focus has centered on unraveling the mechanisms through which
Cullin-RING Ubiquitin Ligase (CRL) complexes orchestrate the three fundamental aspects of cellular life:
growth, proliferation, and survival. Our contributions have been pivotal in elucidating the timing, spatial
dynamics, and biological function of the CRL-mediated degradation of critical cellular regulators. Initially, our
research endeavors were focused on delineating the temporal control of the mammalian cell cycle by the
ubiquitin-proteasome system. Over time, our scope has broadened to encompass three distinct realms of
investigation: cell signaling, cell cycle regulation, and the DNA damage response. This expansion has been
facilitated by our discovery-oriented approach, which, in contrast to traditional hypothesis-driven methods,
remains unbiased. Moreover, the results of these genetics and proteomics screens are not the end goal; they
only set the stage for our mechanistic studies. This process often leads us to unexpected new territories,
expanding our horizons to novel biological processes. Entering new research areas provides us with a broad
vision that is less often attained within compartmentalized fields. Moreover, it enriches us by spurring new
collaborations with other scientists and by prompting us to thoroughly learn new disciplines. The cross-
pollination of diverse fields and ideas is one of the foundations of our modus operandi. In summary, we adopt a
holistic and interdisciplinary approach to provide transformative insights into fundamental biological processes,
particularly those governed by CRLs. The current proposed research endeavors will cover all the mechanistic
studies conducted within our laboratory across the three aforementioned areas. Specifically, we intend to
leverage our established expertise in the ubiquitin field to unearth the molecular mechanisms dictating CRL-
mediated control over signal transduction pathways, cell cycle progression, and DNA repair. Furthermore,
through a blend of biochemical and in vivo analyses, we aim to shed light on the regulatory mechanisms
underlying general cellular homeostasis. Collectively, our expertise in the field of CRLs-mediated degradation,
our validated methods for its investigation, our unique collection of reagents and tools, and the rigor of our prior
research strongly ensure that our studies will continue to uncover novel CRL networks relevant to essential
cellular processes, potentially unveiling novel insights into disease mechanisms.

Public health relevance
PROJECT NARRATIVE/RELEVANCE The family of Cullin–RING ubiquitin ligase (CRL) complexes (~230 members in humans) play pivotal role in virtually every aspect of cell biology, and their deregulation often contributes to oncogenic events. Importantly, an increasing number of therapeutic agents that repurpose CRLs towards neo-substrates (including degraders such as immunomodulatory drugs and sulfonamides) have shown clinical success. Our laboratory's main emphasis lies in delineating the intricate CRL networks governing fundamental cellular processes, unveiling previously undiscovered mechanisms, and, consequently, suggesting new therapeutic approaches applicable to a diverse array of human ailments.